Harnessing novel machine learning approaches for behavioral segmentation and brain signal integration in humanized models of Alzheimer's disease

SUMMARY
Recent advances in computer vision and machine learning (ML), including pose estimation and behavioral
segmentation, offer unprecedented improvements for acquisition and processing of behavioral data. These
approaches enable comprehensive analysis of behavioral patterns frame-by-frame at a millisecond
scale, allowing for the identification of dozens of behavioral states. These emerging methods greatly
expand the depth, breadth, and sensitivity of behavioral quantifications and may provide novel insights into
behavior, brain-behavior interactions, and disease pathogenesis.
We found that these ML platforms, with improved sensitivity and breadth compared to conventional behavioral
tests, are uniquely suited to assess subtle behavioral and cognitive changes in the recently-developed
humanized Alzheimer’s disease (AD) knock-in (KI) models generated by the NIH (MODEL-AD), which express
human proteins at physiological levels and avoid the pitfalls associated with transgenic overexpression. We seek
to determine the co-pathogenic contributions of Aβ, apoE isoforms, and TAU to behavioral and cognitive
functions using these novel humanized AD-KI mice.
The proposal aims to further validate our ML platform for behavioral segmentation, called Variational Animal
Motion Embedding (VAME), and to develop state-space computational models for comprehensive behavioral
phenotyping of spontaneous behavior and cognitive functions in AD-KI mice (Aim 1). We will also perform
validation studies of our ML approaches and computational analyses by introducing established therapeutic or
mechanistic interventions, including reducing TAU expression (TAUKO) or blocking neuroinflammation (Fggγ390–
396A) in AD-KI mice (Aim 2). In Aim 3, we will exploit VAME’s capacity to integrate multi-modal inputs (brain
oscillations and single-unit activity) alongside behavioral patterns to define meaningful relationship between brain
activity patterns and behavioral states across disease progression. We will then use these multi-scale datasets
to enrich our state-space models for assessing navigation in a novel labyrinth maze. As VAME developers, we
will also improve the open-source VAME software and automate our ML pipeline for multi-scale integration to
promote collaboration between computational scientists and translational researchers (Aim 4).
We anticipate that the proposed development of robust and accessible ML and computational tools for behavioral
and brain signal interrogation will drastically reduce some of the challenges associated with conventional
behavioral testing, which often hinder progress in behavioral and translational neuroscience, by improving the
sensitivity, depth, scalability, reproducibility, and statistical power of behavioral studies.

Public health relevance
NARRATIVE Recent advances in computer vision and machine learning (ML), including pose estimation and behavioral segmentation, offer unprecedented improvements for behavioral phenotyping and are uniquely suited to assess the subtle cognitive changes in the recently-developed humanized Alzheimer’s disease (AD) models generated by the NIH (MODEL-AD). We propose to validate and further develop our multi-scale and multi-modal ML platforms for comprehensive behavioral phenotyping of spontaneous behavior, cognitive functions, and therapeutic interventions in newly developed AD KI mice.